Understanding Pulmonary Fibrosis Through the Integration of Complex Occupational and Environmental Exposure Assessments (PF-OEM)

Statement of the Problem: Pulmonary fibrosis (PF) is a chronic lung disease characterized by tissue scarring
and is common in interstitial lung diseases (ILDs). ILDs contribute significantly to global mortality and
healthcare expenses. Some ILDs are considered idiopathic, but research indicates that exposure to inhalants
like vapors, gases, dust, and fumes at work or in the environment can promote fibrosis and inflammation,
leading to PF. Most research focuses on treatments and comorbidities, neglecting the impact of preventable
occupational and environmental exposures. Additionally, marginalized communities with higher exposure rates
are rarely studied. Investigating inhalational exposures can help shape environmental policies and workplace
safety, preventing PF in affected communities and vulnerable workers.
Specific Aims: I aim to use epidemiologic tools to assess the occupational and environmental risk factors and
progression of fibrotic ILD, analyzing a large dataset, the California Electronic Death Registration System (Cal-
EDRS), and an ongoing prospective cohort, the University of California San Francisco UCSF ILD Cohort
Study. In Aim 1, I plan to systematically develop a new PF-specific job-exposure-matrix (PF-JEM) and
measure the association between occupational exposure and PF in the Cal-EDRS. In Aim 2, I will assess the
interaction of environmental and occupational exposures on the occurrence of PF in the Cal-EDRS, using air
pollution data from the CalEnviroScreen and geospatial techniques. To achieve Aims 1 and 2, I will utilize a
case-control study design in the Cal-EDRS to measure the association between occupational and
environmental exposures using multiple predictor models and stratified analysis. Finally, in Aim 3, I will
evaluate the interaction of environmental and occupational exposures on clinical outcomes of IPF in the UCSF
ILD Cohort Study, including survival, using multivariable Cox proportional hazards analysis with stratification.
Significance of the results. The Cal-EDRS and the UCSF ILD Cohort Study offer a unique opportunity to study
the interplay of occupational and environmental exposures on PF utilizing state-of-the-art exposure assessment
techniques of a JEM and residential address geocoding. This study is innovative through its linkage of a novel
PF-JEM to both a rich dataset of vital statistics records and an ongoing cohort study to investigate the risks and
clinical patient outcomes of PF due to inhalational exposures.
Career Development: With the above proposal, Dr. Gandhi will achieve her training goals of 1) Epidemiologic
occupational exposure assessment, 2) Advanced environmental exposure assessment using geospatial
techniques, and 3) Survival analysis and clinical outcomes assessment of exposed patients with ILD. The K23
award will facilitate her transition to independence as a physician-scientist who utilizes innovative
epidemiological methods and exposure metrics to develop a research program focusing on clinical outcomes of
patients with occupational and environmental lung disease.

Public health relevance
PROJECT NARRATIVE: Pulmonary fibrosis (PF), characterized by lung tissue scarring, is the hallmark pathologic finding of interstitial lung diseases (ILDs). Although a large proportion of ILDs are considered idiopathic, early research has demonstrated that occupational and environmental exposure to inhalational vapors, gas, dust, and fumes have profibrotic and inflammatory effects that can lead to PF. To fill these knowledge gaps, the central objective of this K23 Career Development Award is to assess the risk factors and progression of ILD with PF by applying innovative assessment tools for occupational and ambient air pollution exposures in a large population-based dataset, the California Electronic Death Registration System, and a longstanding prospective cohort, the University of California San Francisco ILD Cohort Study.